Master Level Learning

Regarding the mastery learning project for mechanical ventilation in incoming Critical Care fellows, we have collected survey and test data from the summer, winter, and spring for three sets of Critical Care fellows who started their fellowships in 2016, 2017, 2018 and 2019 respectively (N=136). We have also collected data from a second set of incoming fellows with survey and test data from the summer 2020 (N=35). We performed the statistical analysis (by linear mixed model) to determine whether the education program improves test performance and whether decay of knowledge occurs between summer and winter testing as well as winter and spring testing. We published the results in a peer-reviewed manuscript (see bibliography). We have also enrolled fellows who started fellowship in 2021 and 2022 as the program has transitioned to partially virtual and partially in-person to study the effect of virtual vs in-person education on test performance and at the the same time, we are studying the decay of knowledge over time in the cohorts from 2016-2019

Regarding the mastery learning project for mechanical ventilation in respiratory therapists, we have collected survey and test data from June 2017 and January 2018 (N=15). We also collected survey and test data from a second set of respiratory therapists at the VA Pittsburgh (n=14) before and after a day of mechanical ventilation education in spring of 2018 and repeated this with a second day of education in spring 2019. We have conducted the statistical analysis (by linear mixed model) to determine whether the 2 days of Boot Camp education improves test performance and subjective comfort with interpretation of ventilator waveforms. We have submitted a manuscript to Respiratory Care Journal that has now been published.

Regarding the respiratory physiology mastery learning, we have started the curriculum and pre-test with fellows in July 2021 and 2022. We administered a 15-item multiple choice physiology test to the incoming critical care fellows in multiple fellowship programs in Baltimore, Washington DC, and Pittsburgh-same institutions involved the mastery learning in mechanical ventilation project. The fellows performance will be reassessed at the end of each year of fellowship to gauge the progress in physiology knowledge throughout their training.